Defining the host and pathogen determinants of peptidoglycan induced pathophysiology in Lyme disease

ABSTRACT
Accounting for ten times more cases than all of vector-borne diseases combined in the United States, Lyme
disease is an escalating and pervasive problem. Upon infection with the Lyme disease agent—Borrelia
burgdorferi— patients experience mild, flu-like symptoms that can go on to become more severe. In later stages,
even after antibiotic therapy, patients can experience heart, joint, and neurological problems. The reason(s) for
persistent symptoms is poorly understood and the most debated topic in the field. The lead investigator of this
proposal discovered that B. burgdorferi sheds ~45% of its peptidoglycan (PG)—the essential component of the
bacterial cell-wall—from inside the cell, into its environment. B. burgdorferi PG can be detected in the synovial
fluid of Lyme arthritis patients' months after oral and/or intravenous antibiotics. When injected into a mouse, B.
burgdorferi PG alone, is capable of causing arthritis. Virtually all bacteria have PG but, as it turns out, B.
burgdorferi PG is chemically unique and unlike any previously studied. Real-timing PG tracking experiments in
live animals suggest that the unique features of B. burgdorferi muropeptides contributes to both half-life and
discrete tissue localization. These findings led us to hypothesize that shed B. burgdorferi PG fragments contain
unique chemical signature(s) that are required for persistence, Lyme disease pathogenesis, and arthritis. This
proposal will critically test these theories and provide a comprehensive understanding of 1) how and 2) where
PG is able to persist; 3) what molecular features contribute to PG persistence; 4) the mechanistic details that
underlie PG-induced Lyme arthritis; and 5) the importance of muropeptide shedding in the natural life cycle of B.
burgdorferi. Our proposed studies challenge conventional thinking and may lead to a paradigm shift in how we
understand Lyme disease pathogenesis. They may also lead to novel ways to treat patients suffering with Lyme
disease and post-treatment Lyme disease syndrome, even after conventional therapies have failed.

Public health relevance
NARRATIVE Many patients that are suffering with Lyme disease experience chronic symptoms despite having undergone extensive antibiotic therapy and appear to be free of infection. The lead investigator of this proposal discovered that 1) the disease-causing agent sheds a component of its' cell-wall into its environment; 2) this molecule can be detected in patients' months after antibiotics; and 3) the cell-wall, alone, is capable of causing disease pathology. In this project we will determine what about the cell-wall is making us sick and how it is doing so, with the hope that we will be able to leverage this information to treat Lyme disease patients, even when antibiotics fail.